Production and Validation of monoclonal antibodies to enhance rigor and reproducibility in research vertebrate animal model

Project Summary
Animal models are critical for biomedical research. They allow us to rapidly test the importance of any
gene for development or diseases. Advances in technology now allow us to reduce or eliminate protein
expression in the entire animal or in selected tissue. Similarly, mutations in the coding sequence of a
gene associated with a disease can be introduce in animal model to test if they are indeed responsible
for the disease state. Antibodies are critical tools to study protein localization and function. They can
be used to block a protein function, send it for degradation, immunoprecipitate partners associated with
the protein to identify functional complexes. While companies have focused on developing antibodies
to human proteins, and to a lesser extend to mouse proteins, there is a need for antibodies that
recognize proteins in diverse animal models. Despite the close similarity of protein sequences between
human and mouse, many antibodies do not cross react. In addition, some proteins that have been
recently identified or studied have not been targeted. Here we propose to produce antibodies against
selected proteins in mouse, and amphibian (Xenopus and Axolotl) to facilitate the work in these animal
models.

Public health relevance
Project Narrative Scientific research relies on animal model to understand how protein function during embryo development, regeneration and immune reaction. The study of protein function is dependent on the availability of specific antibodies to visualize proteins and identify the composition of protein complex. We propose to produce novel antibodies to proteins for which none are available.